Leveraging Prospective Cancer Epidemiology Cohorts and Novel Methods to Improve Polygenic Risk Scores

Abstract
There are stark differences in the burden of certain cancers across racial/ethnic populations. For
example, in comparison to individuals of European ancestry, African American men have a ~67% higher
incidence rate of prostate cancer and Asian/Pacific Islander men and women have a 70% and 95% higher
incidence rate of liver cancer, respectively. These disparities in the burden of cancer across racial/ethnic groups
have been attributed to an interplay of genetic, environmental, and social factors. Despite such disparities, a
majority of genetic research has focused on individuals of European ancestry. While genome-wide association
studies (GWAS) have successfully identified >1000 risk loci for cancer, they have focused primarily on individuals
of European ancestry. The inadequate representation of diverse racial/ethnic populations limits the translational
potential of GWAS findings to the world's populations. Applying PRS developed in European ancestry individuals
to other populations may result in biased risk prediction, and further exacerbate health disparities due to
inaccurate assessment of individuals at high risk of disease. Here, we propose to address the drastic need for
appropriate PRS construction and evaluation across multiple race/ethnic groups by applying new PRS
approaches to the following six large-scale, longstanding cohorts: the Multiethnic Cohort (MEC); the Kaiser
Resource for Genetic Epidemiology Research on Aging (GERA) cohort; the Women's Health Initiative (WHI);
the Harvard Nurses Health Studies (NHS); the Harvard Health Professionals Follow-Up Study (HPFS); and the
Prostate, Lung, Colorectal and Ovarian Cancer Screening Trial (PLCO). Together, these cohorts include over
300,000 individuals (100,000 non-Europeans) and 91,000 incident cancer cases (24,000 non-Europeans). The
individuals in these cohorts are from five racial/ethnic groups: African Americans, Latinos, Japanese, Native
Populations, and European ancestry. While focusing on cancer outcomes, we will utilize these unique and
extensive resources to develop methods to construct and evaluate PRS, and importantly for translation, estimate
absolute and excess relative risk of cancer jointly for PRS and established risk factors in multiethnic populations.
To facilitate access to developed pipelines and data resources, we will follow F.A.I.R. analytic principles while
participating with the Coordinating Center and other study sites. Ultimately, constructing and evaluating risk
models in non-European ancestry populations is essential to broaden the impact of genomic medicine on human
health.

Public health relevance
Project Narrative This project will construct, evaluate polygenic risk scores (PRS), and estimate absolute and excess relative risk of cancer jointly for PRS and established risk factors in multiethnic populations from six large-scale, longstanding cohorts. This research will inform the development and implementation of risk models across populations to better guide public health screening and potentially inform clinicians and patients in treatment decisions.